BCX 34 IN T CELL MALIGANCIES

BCX -34 is an experimental drug developed by BioCryst Pharmaceuticals Inc., and is being evaluated for use in the treatment of T-cell mediated diseases. It has been tested extensively in animals to show that it is safe. Oral BCX-34 has been tested on 3 patients in an initial study to evaluate its safety. Druging the administration of a single oral dose and a 5 day oral course, no drug related adverse events were noted. This will be the first long-term study investigating the effects of this drug in humans. This trial will last for approximately one year. The purpose is to determine the most effective and least toxic dose of medication needed for a therapeutic response. This will be measured by evaluating levels of drug in the blood an urine, monitoring blood counts for potential abnormalities and assessing the response of the skin and other organs to therapy.